Cardiorenal and Metabolic Diseases Research Center

OVERALL
PROJECT SUMMARY/ABSTRACT
Cardiovascular (CV), renal and metabolic diseases are inextricably linked and are the leading causes of mortality
and morbidity in the U.S., especially in Mississippi which has the highest prevalence in the nation of these
diseases. Cardiorenal and metabolic disorders usually cluster together and are highly interdependent. Obesity
and associated metabolic disorders, such as diabetes mellitus, are major causes of CV and renal disease.
Abnormal kidney function is an important cause as well as a consequence of hypertension, a key risk factor for
CV diseases such as coronary artery disease and stroke. Understanding the complex relationships among CV,
renal, and metabolic disorders and developing new therapeutic approaches requires a paradigm shift in research
that incorporates multidisciplinary integrated approaches, combining the efforts of basic, clinical and population
scientists. A major objective of this Phase 3 COBRE proposal is to amplify the success of Phases 1 and 2 in
developing a leading Cardiorenal and Metabolic Diseases Research Center (CMDRC) that brings together a
multidisciplinary group of basic, clinical and population scientists working on a common synergistic theme, and
to facilitate their collaborations. The specific aims for Phase 3 are: 1) To further develop CMDRC infrastructure,
a well-organized highly productive Pilot Projects Program (PPP), and sustainable research core facilities that
foster excellence in basic, clinical, and population research in cardiorenal and metabolic diseases and increased
competitiveness of CMDRC investigators for independent funding from NIH and other national biomedical
research programs; 2) To enhance CMDRC mentoring and education programs that provide support for PPP
investigators as well as other promising researchers so that they can become productive, independent
investigators who are also effective collaborators on multidisciplinary research teams; 3) To amplify our pipeline
of diverse postdoctoral fellows and students trained in cutting-edge cardiorenal and metabolic diseases research
so they become the next generation of researchers in this field; major emphasis is placed on recruiting and
mentoring underrepresented minority investigators through partnerships with local institutions and by leveraging
training programs at UMMC; 4) To enhance collaborations and interactions among established and junior
investigators from multiple disciplines in cardiorenal and metabolic diseases at UMMC, other IDeA supported
programs, and external partners. These interactions will leverage resources provided by UMMC and other IDeA
programs; 5) To further expand the number of highly productive, extramurally funded cardiorenal and metabolic
disease researchers at UMMC by leveraging institutional resources to recruit additional new faculty with
expertise in clinical and translational research, and in areas where there are gaps in CMDCR expertise. The
CMDRC has been a major driver for marked expansion of cardiorenal and metabolic diseases research in
Mississippi. Phase 3 support will amplify and ensure sustainability of our efforts to develop a highly productive
CMDRC dedicated to improving lives through research, discovery, and innovation.

Public health relevance
OVERALL NARRATIVE Cardiovascular, kidney and metabolic diseases are the leading causes of mortality and morbidity in the United States, especially in Mississippi which has the highest prevalence in the nation of these diseases. This is a critical area for research development in Mississippi in view of the emerging opportunities to develop a comprehensive, multidisciplinary research center at UMMC that focuses on these major causes of mortality and morbidity. This proposal represents a plan for continued development, via Phase 3 COBRE funding, of a unique, Cardiorenal and Metabolic Diseases Research Center (CMDRC) that is dedicated to improving lives through research, discovery, innovation, and translation to prevent and reduce death and disability from cardiorenal and metabolic diseases.